Multiplex gene sequencing and metabolomics analysis from newborn dried blood spots to improve screening and diagnosis of metabolic disorders.

Abstract: Newborn screening (NBS) using tandem mass spectrometry (MS/MS) has transformed our ability to
identify and provide early, lifesaving treatment to infants with inborn errors of metabolism. While MS/MS
screening identifies most affected babies, it is accompanied by frequent false-positive results that require
collecting blood and urine samples for additional confirmatory testing. While DNA sequencing has become an
important part of confirmatory testing, newborn dried blood spots (DBS) yield only small and highly variable DNA
amounts. There is an urgent need for a more efficient second-tier NBS approach for confirming all screen-positive
cases directly from the DBS cards collected at birth. This is especially critical for infants at risk for metabolic
disease in their first weeks of life. The overall objective of this proposal is to combine novel DNA sequencing and
mass spectrometry technology to diagnose inborn metabolic disorders from DBS, and to demonstrate the clinical
feasibility of this approach for second-tier screening. To achieve this objective, the following specific aims will be
pursued: (1) Develop multiplex gene sequencing (RUSPseq) and 10X linked-read sequencing for rapid genetic
diagnosis without the need for additional parental testing; (2) Develop mass spectrometry (Q-TOF/LC-MS) and
Random Forest (RF) machine learning to identify novel metabolic markers, which will be integrated in a novel
second-tier screening panel to separate true and false-positive cases; and (3) Demonstrate clinical and
translational feasibility of this approach to more rapidly identify both true and false-positive cases. We will work
with the public NBS program and NBSTRN’s Pilot Research and Implementation workgroup to translate this
combined approach into second-tier NBS. These outcomes will have significant impact by reducing diagnostic
delays and uncertainties, and by reducing iterative testing rounds and the cost associated with them, thereby
reducing the burden on the healthcare system as well as patients and their families.

Public health relevance
Project Narrative: We will establish novel genetic and metabolomic technology for newborn screening (NBS) from dried blood spots, and apply machine learning to reduce false-positive screens and delayed diagnosis of true-positive cases. Early detection and confirmation of inborn errors of metabolism that can present in the first weeks of life is critical, specifically when screening in diverse multiethnic populations where we have less understanding of the biochemical genetic and clinical phenotypes. We will work with local hospitals and the NBS program to establish clinical and translational validity to this new project, which will contribute to maintaining parental trust in public NBS.